PUBLIC HEALTH CONSEQUENCES OF CHANGES IN THE CANNABIS LANDSCAPE

National Academies of Sciences, Engineering & Medicine (NASEM) - Public Health Consequences of Changes in the Cannabis Landscape: Consensus Study (NCI & NCCIH)